Long-term Impact and Value of Infant Genomic Sequencing (LIVING)

PROJECT SUMMARY/ABSTRACT
The use of genomic sequencing at birth to inform the ongoing care of children has generated great
enthusiasm. Genomic sequencing can act as a screening tool for identifying newborns with existing genetic
disorders; additionally, results can identify newborns with genetic predispositions for future disease that could
be prevented or mitigated through early intervention. In addition, genomic sequencing can help health care
providers manage their patients’ medications by characterizing genes associated with drug metabolism and
modifying medication choices accordingly. These applications and more have raised hopes that genomic
sequencing could complement traditional newborn screening and provide lifelong benefits to individuals and
families. However, great uncertainties exist on how genomic sequencing should be implemented by health
systems and how state newborn screening programs can help genomic sequencing achieve its potential. The
long-term impact of genomic sequencing results on the family are unclear, and projections about how
genomics screening findings will be managed over time are predicated on unverified assumptions that families
and health care providers will be able to access results over time and will continue to follow best practice
recommendations for surveillance of high-risk findings as individuals age. Moreover, the evolving evidence
about gene-disease and gene-drug interactions raises questions about whether, when, and how frequently
molecular laboratories should reanalyze genomic information.
This proposal addresses these key questions about how to ensure newborn genomic sequencing provides
lifelong benefits and value. We will conduct key-informant interviews to understand the needs and concerns of
clinicians, health system leaders, and coordinators of newborn screening programs regarding how newborn
genomic sequencing should be implemented to complement traditional newborn screening, and what systems
need to be designed to maximize their utility over time for children and their families. We will also conduct
follow-up studies of individuals who participated in prior clinical trials of newborn genomic sequencing to
document how health care providers and families utilized genomic information as children aged, and to provide
insight about the benefits and harms that may have accrued. In addition, we will develop a mathematical model
to project the lifelong benefits, harms and cost-effectiveness of different strategies for reanalyzing existing
genomic information over time. The goal of this study is to provide critically-needed evidence about how to
implement newborn genomic sequencing, manage findings, and reanalyze data to ensure newborn genomic
sequencing fulfills its promise as a tool that provides lifelong benefits to individuals and advances public health.

Public health relevance
PROJECT NARRATIVE Genomic sequencing at birth has great potential to improve health not only by identifying infants with undiagnosed genetic conditions, but also by providing information that allows families to prevent disease altogether and to make better medical care decisions. In order for newborn genomic screening to achieve its potential, medical and public health systems will need to adapt existing newborn screening programs, families and clinicians will need to adapt to information and manage findings over long periods of time, and labs will need to reexamine genetic information to ensure findings are up-to-date with new knowledge. This study provides critically-needed evidence that will inform how newborn genetic screening programs should be developed and sustained to provide lifelong benefits.